Plasmonic Nanoantenna Enhanced Ultrasensitive Fluorescence Immunoassay Enabled by Super-hydrophobic Surface

Abstract
Fluorescence immunoassay has been a mainstay in protein detection. Although advanced techniques like
multi-photon excitation and time-resolved microscopy have been routinely performed to increase fluorescence
intensity, unfortunately, these incremental changes alone cannot bring the fluorescence intensity level high
enough for meeting the growing biomedical research needs for ultralow and ultrasensitive detection crucial for
early diagnosis. A paradigm shift that fundamentally transforms existing fluorescence technology relying on linear
fluorescence emission is necessary. One such transformative technique explores localized surface plasmon
resonance (LSPR) in a nanoantenna to trigger the nonlinear fluorescence emission. This nonlinear optical
process can enhance fluorescence intensity by several orders of magnitude, holding the promise to support high-
resolution biosensing. However, the nanoantenna technique is still far from being routinely implemented in
biological and biomedical fields due to a major obstacle not from plasmonics but from the mass transport: Most
of nanoantennas typically rely on diffusion to capture interested molecules. The diffusion limit makes the
nanoantenna-enhanced fluorescence only theoretically possible. This critical technology gap will be bridged by
the technology proposed here. This project proposes a new technology by the fusion of the nanoantenna and
super-hydrophobic surface to break the diffusion limit. Droplets over super-hydrophobic surfaces maintain quasi-
spheres during evaporation and do not wet the surface. Now the droplet evaporation replaces the diffusion and
concentrates molecules onto the sensitive regions of the nanoantenna, becoming the dominant mechanism of
mass transfer. The combination of plasmonic nanostructures and super-hydrophobic surfaces offers a unique
solution to the key challenge in the nanoantenna-based detection: difficulty in practically bringing molecules to
nanostructures. The specific aims of this application are to test that the integration of nanoantenna with the
super-hydrophobic surface is capable of enhancing (1) the fluorescence intensity; and (2) the fluorescence
immunoassay's detection sensitivity. This research will contribute to the paradigm shift of fluorescence
technology. Since chips with deposited nanoantenna can be viewed through a regular fluorescence microscope
with much improved capability, the devices produced by this research can be readily implemented in existing
analytical platforms with little additional cost, which will have a major impact on the biomedical field.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed work will accelerate ongoing efforts of implementing surface plasmon resonance fluorescence immunoassay. The developed immunoassays will find important applications in biomedical fields including expression profiling, high-throughput proteomics, and early detection of many diseases such as cardiovascular diseases, cancer, and infectious diseases.